MicroRNA Correlates of Childhood Maltreatment and Suicidality

The purpose of this project is to determine if the relationship between a history of childhood maltreatment (CM)
and suicide risk is associated with alterations in the expression and epigenetic modification of specific
microRNAs (miRNAs), thereby providing a molecular signature of suicide risk in people with a history of CM. We
propose that whereas both major depressive disorder (MDD) and suicidality are complex phenotypes, CM alters
the risk threshold for both. Epigenetic changes caused by early stressful events can induce long-term alterations
affecting networks of genes. miRNA expression represents one of the central mechanisms for environmental
regulation of gene expression. miRNA sequences themselves are epigenetically modified. The sum of these
effects may explain long-term cellular (mal)adaptations which may lead to suicide vulnerability in the CM
population. Using a specific cell surface marker, we isolated neural-derived exosomes from blood plasma and
found that these exosomes were not only enriched with brain expressed miRNAs, but also showed a unique set
of miRNAs that were associated with CM and suicidality. Changes in the same set of miRNAs were also noted
in the brain of suicide subjects with a history of CM. In addition, suicidal subjects with and without CM showed
differential regulation of miRNAs in response to acute stress, a short-term risk for suicidal behavior, particulay in
the context of CM. Moreover, miRNA expression changes were highly correlated with exosomal miRNA promoter
methylation. Based on our preliminary data, we propose an overarching hypothesis that there are multiple
paths to suicidal behavior, and CM represents a unique path that is associated with altered expression and
epigenetic modification of a specific set of miRNAs and concomitant downstream specific target genes and
network(s). To test this, we will: 1) identify a set of neural-derived exosomal miRNAs that are associated with
the interaction of suicidality and CM severity while controlling for the independent effects of suicidality, CM, and
MDD; 2) examine whether an acute experimental stressor differentially impacts the expression of neural-derived
exosomal miRNAs in suicidal patients with and without CM; 3) use bioinformatic tools to examine potential
mechanisms by which altered neural-derived exosomal miRNAs may contribute to CM-associated suicidal
behavior; and 4) examine if changes in CM-associated miRNAs are explained by modifications in their DNA
methylation. In participants (n=450; replicated in a cohort of 350 subjects) across the spectrum of MDD, suicide,
and CM severity, we will test for the main effects of each, and identify a subset of miRNAs that are associated
with suicidality and CM severity. We will also test for the independent main effects of CM or suicidality on miRNAs
and the interactions among those factors. Altogether, using a distinct study population, unique neural-derived
plasma exosomes, and innovative molecular, biostatistical, and bioinformatic tools, our study will identify: 1)
neural-derived plasma exosomal miRNAs as a novel biosignature of suicide risk in the context of CM that can
be tested in longitudinal studies, and 2) potential mechanisms by which CM can act as a risk factor for suicidality.

Public health relevance
Childhood maltreatment is a major risk factor for suicidal behavior; however, the molecular mechanisms by which childhood maltreatment impacts suicidality, is not known. MicroRNAs are important transducers of environmental effects on gene expression products; this work will test the effects of both childhood maltreatment and an acute experimental stressor on brain microRNAs in humans using a novel method of isolating neural-derived plasma exosomal microRNAs from peripheral blood. By examining microRNAs as mediators of childhood maltreatment- induced suicidality, this study will identify potential molecular mechanisms by which childhood maltreatment can act as a risk factor for suicidality, and neural-derived exosomal microRNAs as novel biosignature of suicide risk in the context of childhood maltreatment that can be tested in longitudinal studies.